Massage for GAD: Neuroimaging and clinical correlates of response

GAD is a disorder of increased emotional reactivity, with its cardinal symptom, persistent worry, comprising an
avoidance mechanism that decreases emotional reactivity to contrasting negative emotions. Evidence-based
research has shown that both cognitive behavioral therapy (CBT) and selective serotonin reuptake inhibitor
antidepressants are efficacious treatments for GAD; however, there is a need for additional acceptable, and
widely available treatment approaches for patients suffering from GAD. Massage is a multi-billion dollar
industry and in 2016-2017, over 47.1 million adult Americans received at least one massage. Massage is
commonly used to increase the overall sense of wellbeing and decrease anxiety and our group has
investigated the impact of Swedish massage therapy (SMT) on psychiatric symptoms and physiology. In a 6-
week study of twice-weekly SMT vs a light touch (LT) control for GAD, SMT caused statistically significant
decreases in anxiety and depression - demonstrating that SMT is biologically active and can impact symptoms
of anxiety. Although imaging results in GAD remain inconsistent reduced functional connectivity (FC) within the
corticolimbic circuit (amygdala, anterior cingulate cortex (ACC), prefrontal cortex (PFC)) is one of the most
consistent findings. At this time there are no brain imaging studies investigating the impact of any type of whole
body massage on brain function. The overall goal of this proposal is to identify the neural networks impacted
by whole body massage in subjects with GAD. This study is a two-arm, randomized, masked study
investigating the effects of SMT vs. LT control on brain activity in subjects with GAD. Medically healthy
subjects ≥18 years of age with GAD will undergo fMRI followed by 2/week SMT (n=20) or LT (n=20) for 6
weeks, followed by a second fMRI. Resting state functional connectivity (rsFC) and FC during the fearful/angry
faces task will be assessed. Aim 1 is to identify brain networks activated by SMT vs. LT using resting state
fMRI and FC during the fearful faces task in subjects with GAD. The primary hypothesis is that relative to the
LT control, SMT will result in greater pre-to- post-treatment increase in rsFC between areas known to be
altered with anxiety disorders. Second, relative to LT control, subjects undergoing SMT will exhibit less
activation in response to the fearful/angry faces task, as well as a greater pre-to-post-treatment decrease in
brain activation. Lastly, it is hypothesized that pre-to-post-treatment increases in rsFC will inversely correlate
with decreases in changes HAM-A scores, whereas pre-to-post-treatment decreases in brain activation in
response to the fearful/angry faces task will be positively correlated with decreases in HAM-A scores within
both treatment groups. Completion of this study will provide the first fMRI data evaluating the effects of SMT in
comparison to an active control condition, on specific areas of brain connectivity and activity in subjects with
GAD.

Public health relevance
Generalized Anxiety Disorder (GAD) has a lifetime prevalence between 4-6% and is highly distressing and disabling to patients and their loved ones. We have demonstrated that 6 weeks of Swedish massage therapy decreases the symptoms of anxiety and depression in subjects with GAD. The proposed study will investigate the effects of Swedish massage therapy on brain activity in subjects with GAD.